Clinical Science Core

Project Summary Clinical Science Core (CSC)
The Midwest D-CFAR Clinical Science Core (CSC) is committed to addressing the persistent clinical
challenges posed by HIV and its related conditions. Despite significant progress in combating clinical AIDS
through antiretroviral therapy, HIV-related conditions – especially syndemic factors like mental health issues,
drug use, and unstable housing – continue to impact the epidemic in Missouri. Additionally, as the HIV-positive
population ages, comorbid clinical conditions such as cardiovascular disease, metabolic disorders, mental
health, and impaired cognitive function contribute significantly to healthy life-years lost. To tackle these
complex issues, the CSC aims to support creative and interdisciplinary investigator-initiated clinical scientific
projects. The Washington University and Saint Louis University collaborative environment is conducive to this
effort, boasting a rising class of energetic clinical researchers seeking NIH funding and a rich environment for
HIV clinical research with substantial annual funding. However, the existing infrastructure has not been fully
leveraged for investigator-initiated research. To address these gaps, the CSC plans to use infrastructural
funding from a D-CFAR to foster synergies, increase the number of investigator-initiated trials, and expand
clinical research into HIV-related comorbid conditions. Their specific objectives are: Aim 1. Provide
streamlined training, consultation, and support for foundational clinical research practices, including study
coordination, protocol development, ethical and regulatory approval, and access to clinical trial unit facilities.
By leveraging their expertise in clinical trials and successful enrollment of diverse populations, the CSC seeks
to support a growing cadre of innovative and interdisciplinary clinical research projects. Aim 2. Offer key
resources and support throughout the research process, from idea generation to pilot funding applications, with
a focus on accelerating interdisciplinary research addressing HIV comorbidities and co-occurring conditions.
Through events like Transdisciplinary HIV Studios and coordination of pilot data collection, the CSC aims to
facilitate cross-disciplinary scientific dialogue and maximize the utilization of existing clinical research
infrastructure. Aim 3. Provide specialized resources in analytical, biostatistical, data management, and
geospatial analysis for clinical research in HIV. To address the unique analytical needs of HIV-related
research, the CSC will offer a one-stop-shop for consulting services and specialized training sessions for junior
investigators. The CSC will bring together new collaborators and novel ways of thinking about issues relevant
to addressing the ongoing epidemic, improving care for long-term consequences of living with HIV, particularly
in underrepresented populations, and identifying and evaluating strategies to address HIV treatment,
prevention, and cure.